WashU-Northwestern Genomic Variation and Function Data and Administrative Coordinating Center

PROJECT SUMMARY
The goals of the WashU-Northwestern Genomic Variation and Function Data and Administrative
Coordinating Center (IGVF-DACC) component of the IGVF Consortium are to collect, store, curate, and display
all data, metadata, and analysis tools generated by the IGVF Consortium. The DACC will assist in developing
and disseminating metadata and standards to be adopted by the community at large, approaches for integrative
analysis of a wide range of data types, and visualization and analysis tools to facilitate access and understanding
of complex datasets to non-expert users. Ultimately, the IGVF Consortium will produce tools, analyses, models,
and data that form the catalog of variants and their functional impact. We will develop the DACC into a substantial
service organization allowing scientific research to take full advantage of the IGVF reference catalog or map. To
support the IGVF Consortium, we will establish databases with an application framework to facilitate complex
data loading. We will include detailed experimental descriptions and metadata. We will define and develop
pipelines that connect all Consortium members to the data and create avenues of access that distribute the data
to the greater biological research community. We will establish metadata requirements, controlled vocabularies,
standardized data formats, and quality control metrics for all IGVF data. We will bring together laboratories that
generate complex data types via experimental assays with laboratories that integrate these data using
computational tools to define the effects of genomic variation on genome function and how these effects shape
phenotypes. By creating structures and data flow pipelines for the verification and validation of all data and
providing processes for the documentation of metadata, the DACC will enhance the IGVF data production. The
DACC will also coordinate integrative data analysis by creating and adapting analysis pipelines and developing
advanced Genome Browser functions for the visual integration of IGVF data. Also, we will make the IGVF Web
Portal that will be the primary entry point to the wealth of experimental data and computational analyses. The
Portal will integrate these data resources and make them available via enhanced search and browsing
capabilities. Finally, the DACC will provide documentation, training, and outreach via many media, including
written documentation, video tutorials, online books, webinars, and meeting workshops and presentations.

Public health relevance
PROJECT NARRATIVE The relevance of this work for public health is that the comprehensive determination of how genomic information specifies proper execution of spatial and temporal gene expression programs is essential for understanding how cells divide or respond to their environment, for identifying the regulatory mechanisms that control development, for learning dysregulation in disease, for studying phenotypic variations among human populations, and for determining the clinical significance of genomic variation.